The Ohio Valley Node of the Clinical Trials Network

Using Integrative Data Analysis to Examine the Impact of Psychosocial Treatments for Black Cocaine Users Enrolled in the NIDA Drug Abuse Treatment Clinical Trials Network (CTN) Specific Aims Recent reports reveal that the acceleration of opioid-involved overdose deaths for Black people now outpaces that of White people.1 This increase is attributable to the presence of synthetic opioids (fentanyl) in the cocaine supply in approximately one third of opioid overdose deaths. The limited body of work available suggests that treatment effectiveness may vary across racial- ethnic groups. Yet, only a subset of these studies have specifically looked at cocaine use. The CTN provides a unique but underexplored collection of studies that can improve our knowledge on effective psychosocial treatments for Black people who use cocaine. The proposed study will combine data from 7 CTN treatment studies (total N = 1442 Black participants) that in combination present mixed findings. Using multiple emerging measurement/data analysis frameworks (integrative data analysis (IDA), meta-analysis of individual patient data (MIPD), causal moderation analysis), the goal of the proposed study is to evaluate the effectiveness of substance use disorder treatments for Black people who use cocaine. The project has three specific aims: Aim 1: Estimate scale scores of cocaine use severity while considering study-level measurement non-invariance. Aim 2: Compare the effectiveness of evidence-based treatment models for cocaine use severity. Aim 3: Explore individual- and study-level moderators, such as concomitant opioid use, age, sex, employment, pre-treatment psychiatric status, and retention to evaluate subgroup differences in treatment effectiveness.

Public health relevance
Using Integrative Data Analysis to Examine the Impact of Psychosocial Treatments for Black Cocaine Users Enrolled in the NIDA Drug Abuse Treatment Clinical Trials Network (CTN) Specific Aims Recent reports reveal that the acceleration of opioid-involved overdose deaths for Black people now outpaces that of White people.1 This increase is attributable to the presence of synthetic opioids (fentanyl) in the cocaine supply in approximately one third of opioid overdose deaths.2 The limited body of work available suggests that treatment effectiveness may vary across racial-ethnic groups.3–7 Yet, only a subset of these studies have specifically looked at cocaine use.3,6 The CTN provides a unique but underexplored collection of studies that can improve our knowledge on effective psychosocial treatments for Black people who use cocaine. The proposed study will combine data from 7 CTN treatment studies (total N = 1442 Black participants) that in combination present mixed findings. Using multiple emerging measurement/data analysis frameworks (integrative data analysis (IDA), meta-analysis of individual patient data (MIPD), causal moderation analysis), the goal of the proposed study is to evaluate the effectiveness of substance use disorder treatments for Black people who use cocaine. The project has three specific aims: Aim 1: Estimate scale scores of cocaine use severity while considering study-level measurement non- invariance. Aim 2: Compare the effectiveness of evidence-based treatment models for cocaine use severity. Aim 3: Explore individual- and study-level moderators, such as concomitant opioid use, age, sex, employment, pre-treatment psychiatric status, and retention to evaluate subgroup differences in treatment effectiveness. Research Strategy a. Significance. The impact of identifying effective cocaine use treatments among Black people who use substances would be high. Although the opioid epidemic has ravaged many communities in the U.S., cocaine overdose death rates are inextricably linked to the opioid crisis in Black communities.9 In 2017, Black adults had both the highest rate (8.3 per 100,000) and the largest relative rate change from 2016 (36.1%) of cocaine-involved deaths.10 These increases in cocaine overdose deaths are primarily driven by synthetic opioids.10 Thus, understanding cocaine addiction and treatment is now more than ever a high priority issue among Black people. The proposed project will contribute substantially to the information that providers can use to determine the most appropriate treatments for Black people who use cocaine. Despite strong evidence of the efficacy/effectiveness of psychosocial treatments for SUDs within the CTN, the comparative effectiveness of these treatments for Black people who use cocaine remains unknown. Our recent scoping review identified few trials that reported outcomes specific to Black participants.8 Moreover, much of this work involved secondary analyses. Convincing evidence suggests that Black substance use is inextricably intertwined with social determinants of health (e.g., quality healthcare)11 and other social contextual factors (e.g., lifestyle).12,13 Thus, we hypothesize that CTN tested substance use treatments that also address factors such as lifestyle conditions, co-occurring disorders, and self-efficacy [Motivational Enhancement Therapy (MET), STAGE12 (Twelve Step Facilitation), Seeking Safety, and Therapeutic Education System (TES)] will have better outcomes among Black adults than treatments which solely focus on substance use behaviors [Motivational Incentives (MI) in drug free clinics, MI in methadone clinics, and Screening Brief Intervention and Referral to Treatment (SBIRT)]. Few analyses exist of moderators of treatment outcomes across evidence-based SUD treatment models for Black people who use cocaine. The scope of the literature assessing the effectiveness of cocaine treatment programs focuses on race comparison studies (e.g., Black people vs White people) which disregards the influence of measurement non-equivalence between racial groups in assessing treatment effectiveness.14,15 Furthermore, what may appear to be racial/ethnic differences in these studies could be attributable to contextual factors in site selection (private vs public clinics), differences in retention, treatment adherence, and/or attrition16–18 or other socio-demographic differences (e.g., access to treatment), which may be specific to a given racial/ethnic group and not easily controlled for in this setting.19 In this vein, studies that consider within group differences in treatment effectiveness among Black individuals who use cocaine are imperative to explain treatment effectiveness within this population. For example, within group differences in psychosocial variables (e.g., age, sex, gender identity, employment) are likely present and certain subgroups of patients may benefit differently across specific types of therapies. According to the National Vital Statistics System, the percentage of cocaine overdose deaths involving any opioid increased from 29% to 63% between 2000 and 2015.20 Our review of CTN data revealed that information is available on whether 1271 of the 1442 Black participants in the selected protocols used opioids at baseline. Therefore, we are also including concomitant use of opioids as a moderator variable. b. Innovation. This project is novel because it will clarify which types of treatments are most beneficial for varying subgroups of Black cocaine users by combining multiple key measurement and analysis frameworks. Though this study is not a meta-analysis per se, MIPD methods are useful in the simultaneous assessment of study- and individual-level predictors of treatment efficacy and individual-level effects. The latter cannot be examined in conventional meta-analysis.21,22 IDA creates comparability in measures across studies that may assess a given construct in different ways. Both methods save on resources by utilizing existing data sets to inform which SUD treatments are most efficacious in improving cocaine treatment outcomes among Black individuals. Causal moderation methods address bias due to unmodeled treatment x covariate interactions when assessing treatment x moderator interaction effects; a source of bias that can happen when moderators are not randomized even if the treatment conditions are.23 Another innovation is that the study contributes to the training of early career investigators from underrepresented groups through linkage with the Learning for Early Careers in Addiction & Diversity (LEAD) program (R25 at UCSF), a science education grant that builds on the CTN platform. The LEAD Program is integrated within the CTN through the Western States Node. LEAD scholars will participate in intensive on-site training on secondary data analysis methodology with Antonio Morgan-Lopez at RTI International. The dataset, once harmonized, will create numerous publishing opportunities for the LEAD scholars. Drs. Carmen Masson and LaTrice Montgomery will serve as the liaisons between the research team and LEAD. c. Approach. This study builds on several previous projects. First, we are currently combining MIPD and IDA in two currently-funded R01s (R01AA025853, Hien, D.A. & Morgan-López, A.A., MPIs; R01MH124438, Lochman, J.L. & Morgan-López, A.A., MPIs). Second, our earlier scoping review of CTN data sets14 identified 46 published articles (not protocols) that met the following criteria: (1) published CTN studies and (2) at least 75% of the sample was Black or reported findings specific to Black people. To identify the protocols associated with those publications for the proposed study, we added the following criteria: (1)100 + Black participants (2) behavioral intervention (3) protocol assessed cocaine use at baseline and follow-up time points (4) follow-up data on cocaine use collected during the 4-6 month follow up period as defined by each protocol. The 7 protocols meeting these criteria include MET (0004), MI in drug free clinics (0006), MI in methadone clinics (0007), STAGE 12 (0031), TES (0044), SBIRT (0047) and Seeking Safety Treatment (0015). Cases from these protocols will be included if the participant enrolled in the protocol, self-identified as Black, and reported cocaine use during the 30 days prior to enrollment in the study. Consistent with a harm reduction perspective, the primary outcomes include abstinence from cocaine and reductions in days of cocaine use [assessed as low frequency (1-4 days/month) or high frequency (5+days/month)].24 The secondary outcomes include attendance and retention. Aim 1: Estimate scale scores of cocaine use severity while considering study-level measurement non- invariance. We have identified available measures/scales across the selected CTN protocols that include urine toxicology screens and at least one, if not multiple self-report indicators of cocaine use per study. Based on past25 and current experience with IDA,26 we believe there is sufficient overlap in measures across the selected studies for cocaine severity scale score estimation in the presence of “missing” scales. Moreover, the methodology can handle harmonizing items by assessment periods across studies (as we are currently doing in R01AA025853 and R01MH124438). Although variations in study designs and assessment time across trials might present challenges when pooling the data, multilevel latent curve models allow for varying times of observations across individuals and studies.27 After item- level data are structured, we will estimate longitudinal non-linear factor analysis models,28 which our group has used extensively,15,29,30 that accommodate both categorical and continuous indicators and consider differences in measurement properties over time and across groups. This approach will allow for the examination of changes in cocaine use severity (free of measurement non-invariance) in subsequent aims. Aims 2 and 3: Compare the effectiveness of evidence-based treatment models for cocaine use severity. Explore individual- and study-level moderators to evaluate subgroup differences in treatment effectiveness. The primary analysis framework will be three-level random coefficient modeling with random treatment effects in SAS Proc MIXED. At Level 1 (within-individual), we will estimate two random effects capturing linear growth over time (and will accommodate non-linear change if necessary, see e.g., Morgan- Lopez et al., 2014, 2013):31,32 a random intercept (cocaine severity MNLFA score at baseline) and a random slope (estimated change in cocaine use severity). These values will vary across individuals within study. Within Level 2 (between-individual), there would be key individual-level predictors of change in cocaine use severity, with the key predictor being a 0/1 dummy treatment indicator indicating whether an individual was in the active treatment versus comparison condition within each study and whether there were differences in treatment trajectories across treatment arms (Aim 2). As substance use often coexists with other social conditions that impact Black individuals, Aim 3 will examine socio-demographic factors that influence treatment efficacy. To do so, the models used to address Aim 2 also will include individual- and study-level moderator effects such as opioid use at baseline, age, sex, employment, retention, and pre-treatment psychiatric status (Aim 3). These models will include random treatment effects across studies, so that study-specific effect sizes can be calculated much as would be the case in a traditional meta-analysis with summary data. Causal moderation propensity weights will be estimated and included to mitigate treatment x covariate interaction bias.23 In this way, our concept will adequately identify the influence of social factors on treatment efficacy. D. Timeline. Months 1-4: General orientation and on-site training of LEAD Scholars; Finalize Design; Obtain IRB approval. Month 5-6: Identify eligible cases; Months 7-9: data organization and harmonization of drug and moderator measures (Aim 1); Months 10-14: conduct main analyses to address Aims 2-3; Months 15-18: Write up results; submit first publication; disseminate findings at national conferences. E. Public Health Impact. Cocaine is the number two killer amidst illicit substances and is responsible for more deaths among Black adults than heroin. There has been a historic surge in cocaine-related deaths among Black adults, largely fueled by fentanyl, an opioid often mixed with cocaine. Evidence-based psychosocial treatments exist for cocaine. However, few studies have examined whether these treatments are effective for Black people who use cocaine. F. Suitability, Feasibility, and Sustainability for the CTN. The CTN is uniquely suited for this study because it houses a substantial collection of data sets evaluating alternative substance use interventions in randomized clinical trials. This database has a subsample of Black participants that is likely one of the largest in multiple treatment trials. G. Research Team. (See budget justification for more detailed biographical information). The study will be conducted by a multidisciplinary, multi-racial/ethnic team of researchers familiar with CTN research. Kathy Burlew (MPI), the chair of the Minority Interest Group of NIDA's Drug Abuse Treatment Clinical Trials Network (CTN), will draw on her 4 first-authored CTN affiliated publications on culturally competent research methods and other secondary research projects examining the efficacy of CTN and other interventions for Black people. Lesia Ruglass' (MPI) research interests center on understanding and reducing health disparities related to SUDs (particularly opioid use, cannabis use, and tobacco use disorders), She has served as Project Director or Co-I on multiple R01 trials and is currently co-investigator on a recently-funded MIPD/IDA R01 from NIAAA assessing treatments for comorbid PTSD and SUDs. Antonio Morgan-Lopez (Co-I) has served as PI on five grants funded by NIDA, NIAAA and NIMH focused on methodological issues in modeling behavioral treatment data. This includes a completed NIDA R01 to re-analyze data from CTN protocol 0015 and a currently-funded MIPD/IDA R01 from NIAAA to harmonize data from 42 RCTs for comorbid PTSD and SUDs. In the proposed study, he will adapt his methodology to conduct the planned analyses. Adriana Espinosa's (Co-I) work highlights psychosocial factors that explain differences in health-related behaviors, including medical adherence across racial/ethnic groups, including Black and Latinx individuals. Angela Haeny is a LEAD scholar whose research focuses on improving drug and alcohol treatment access, retention, and outcomes among people of color. Ayana Jordan's (Co-I) is an addiction psychiatrist whose research interests center on increasing access to evidence-based treatment modalities for under-represented minority patients with SUDs. She is currently PI of a NIAAA R01 trial studying the role of faith based institutions in delivering evidence-based treatment for Black people with SUDs. Drs. Carmen Masson and LaTrice Montgomery will serve as Liaisons to LEAD.